Sine Oculis Homeobox Homolog 1 and clusterin in Pulmonary Hypertension associated with Systemic Sclerosis

Abstract / Project Summary:
Systemic sclerosis (SSc) is a heterogenous autoimmune disease that disproportionately affects African
American women. The etiology of SSc is not fully understood, a subset of patients develops pulmonary
hypertension (PH), a fatal disease that is characterized by a mean pulmonary arterial pressure (mPAP)
of 20 mmHg at rest. PH in SSc can happen on its own, termed SSc-PAH or in combination with
interstitial lung disease (ILD), a common complication in SSc that is characterized by fibrotic deposition.
Hallmarks of PH include vascular remodeling and right-ventricle (RV) dysfunction. Despite advances in
care for PH, many patients with PH including those with SSc, require lung transplantation for survival,
despite the dire 5-year survival rate of this procedure. This underscores the need to identify new
treatments for SSc-PH. A hallmark of PH is vascular remodeling, a complex process that involves injury
to endothelial cells and subsequent proliferation of both the endothelial and smooth muscle layer of the
vasculature. Changes in cell metabolism, and activation of de-differentiation pathways have been
reported to play an important pathophysiological role in vascular remodeling. Exciting preliminary
results from our group have revealed increased expression of the developmental transcription factor:
Sine Oculis Homeobox Homolog 1 (SIX1) in remodeled vessels from patients with SSc-PH. These
results are significant since SIX1 is known to promote cell proliferation and differentiation. Our group
has demonstrated that SIX1 plays a role in lung fibrosis by stimulating the expression of clusterin (CLU),
a mediator that is associated with SSc and PH, where it may promote autophagy. Several isoforms of
CLU exist through alternative splicing including secreted (s) CLU. Thus, the aim of our study is to
determine the expression levels of SIX1 and its co-factors: eyes absent (EYA1) and EYA2 as well as
downstream target sCLU in pulmonary artery smooth muscle cells (PASMC) from patients with SSc-
PH. We will then evaluate the mechanisms that are activated in SSc derived PASMC following
treatment with exogenous sCLU and evaluate signaling pathways that promote autophagy and cell
proliferation. Next, using SIX1 loss of function mice, we aim to uncover the role of SIX1 in an
experimental model of PH.

Public health relevance
Narrative: Pulmonary hypertension (PH) can develop in patients with Systemic sclerosis (SSc), a heterogenous autoimmune disease; where there are limited treatment options outside lung transplantation. Preliminary results from our group demonstrate elevated levels of Sine Oculis Homeobox Homolog 1 (SIX1) and clusterin (CLU) in patients with SSc-PH; however how SIX1 and CLU contributes to PH is not known. The goal of this project is to determine the expression profile of SIX1 in SSc-PH and to evaluate the role of therapeutic capacity of SIX1 in PH.